Engineering commensal bacteria and probiotics for lactate conversion and treatment of sepsis

Abstract
The gut microbiota and its metabolites play a crucial role in the clinical progression of sepsis, a leading cause of
morbidity and mortality worldwide. Early evidence shows that engineered live bacterial therapeutics (LBTs) can
be used to treat impaired systemic metabolism and immunity. Attempts at probiotic therapies for sepsis have
been limited to traditional probiotic formulations with mixed results, in part due to poor engraftment and unclear
mechanisms of action. Lactic acidosis is frequently observed in many conditions including sepsis, where it is
strongly associated with poor clinical outcomes. Recent evidence indicates that circulating lactate enters the gut,
where it can be fermented by commensal bacteria into beneficial byproducts which support organ function. The
influence of the gut microbiota makes sepsis patients an ideal target population for synthetic probiotic therapy
approaches, and the prevalence and availability of lactate during sepsis makes it an ideal substrate for the
production of metabolites with therapeutic benefit. To leverage these factors, I propose to optimize and evaluate
a probiotic platform to which optimizes gut microbial conversion of lactate to pyruvate, leading to the enrichment
of molecules shown to be beneficial in sepsis models. Preliminary data indicates that 1) anti-anaerobic antibiotics
worsen patient outcomes and hinder rates of systemic lactate conversion and that 2) oral administration of
Bacillus subtilis engineered to express lactate oxidase (LOX) can accelerate systemic lactate conversion in
murine models of lactic acidosis. These exciting findings prompt evaluation of the therapeutic efficacy of LOX
expressing bacteria in the context of sepsis. With that said, the existing B. subtilis model is limited by poor
engraftment, potentially leading to suboptimal efficacy and translation to chronic conditions. In this application, I
propose to utilize the cecal slurry mouse model to evaluate the ability of LOX expressing bacteria to curtail sepsis
severity, promote survival, and mitigate inflammation and organ damage (Aim 1). Concurrently, I will address
limitations in the current B. Subtilis model by integrating LOX into native Escherichia coli with superior
engraftment. This new model will contain circuity for lactate import and pyruvate export along with a CRISPR-
based kill switch to ensure safety and biocontainment (Aim 2). The resultant strain will be evaluated for safety,
colonization, and ability to curtail sepsis (Aims 1 and 2). Finally, both the B. subtilis and E. coli models will be
used for in vivo ‘pulse’ experiments utilizing radiolabeled lactate to identify metabolic pathways influenced by
their administration, identifying additional disease states for future applications (Aim 2). Building on existing
patient data which identified a candidate mechanism of action, these projects seek to bridge the translational
gap between microbiome engineering and human critical illness by leveraging lactic acidosis for the production
of therapeutic byproducts. Given the vast array of disease states associated with impaired lactate and pyruvate
metabolism, this platform has broad potential applications beyond sepsis. As a result, completion of this work
will result in a potential low risk, scalable, and convenient therapeutic option for a wide range of pathologies.

Public health relevance
Project Narrative The gut microbiota and its metabolites play a crucial role in the progression of sepsis, but effective probiotic therapy approaches are lacking. Based on preliminary clinical data suggesting lactate conversion by the gut microbiota to be an important factor in septic patient outcomes, we propose to optimize and evaluate the ability of a previously established probiotic strain, which converts systemic lactate to pyruvate, to curtail severity of a mouse model of sepsis. Features such as durable engraftment and biocontainment will be added to the optimized lactate converting probiotic, enabling it to bridge the translational gap between human critical illness and bacterial engineering by providing a potentially transformative therapeutic option for sepsis and other lactate associated diseases.